Viral Innovation Core

PROJECT SUMMARY: Viral Innovation Core
Viral vectors are used extensively in neuroscience research to deliver an ever-expanding toolkit of genetically
encoded reagents that can disrupt or modify gene expression, control the excitability of cells within circuits,
identify connections within and across brain regions, and help visualize real-time indices of cellular activity and
neurotransmission with spatial and temporal precision. Adeno-Associated Virus (AAV) vectors are commonly
used for this purpose given their broad tropism, ability to promote stable gene expression, and low cytotoxicity
and immunogenicity profiles. AAV vectors are used by many investigators within the University of Minnesota
(UMN) addiction research community. The demand for AAV vector production within this group has grown
steadily since the founding of the UMN Viral Vector and Cloning Core (VVCC) in 2017, driven in large part by
faculty hiring in the addiction neurosciences and NIH/NIDA support for the Center for Neural Circuits in Addiction
and its Viral Innovation Core/VIC. The goal for the VIC in the next funding period is to sustain its positive impact
by meeting the expanding AAV vector needs of the UMN addiction research community. The mission of the VIC
is encapsulated in two AIMs: 1) Generating AAV vectors to support the UMN addiction research community. In
the initial project period, the VIC exceeded critical benchmarks related to AAV production, while also fueling the
development and optimization of a pipeline of advanced vector characterization assays to evaluate AAV vector
quality. In the next funding cycle, the VIC will build on its positive impact by increasing its support for AAV vector
generation – including custom vectors that are in high demand – for the growing UMN addiction research
community. Centralization of AAV production represents a critical efficiency for Center Investigators and
Affiliates, many of whom apply these tools to projects supported by other Research Cores. 2) Special Projects:
Engineering tropism of AAV. In the initial project period, the VIC supported research into the “engineerable
capacity” of the AAV backbone. We were successful in identifying new capsid regions and strategies for adding
binding scaffolds (e.g., nanobodies) without impairing virus yield, post-entry steps, and infectivity. In the next
funding cycle, the VIC will leverage these new opportunities for viral vector engineering to test the hypothesis
that combining genetic elements for viral payload expression (e.g., promoters and enhancers) with receptor-
mediated virus binding will result in synergy to more specifically target desirable cell populations of interest to
addiction researchers. Summary. Tools generated by the VIC will meet the needs of Center Investigators and
Affiliates as they pursue their innovative research projects and will promote engagement with the other Research
Cores. Furthermore, new multi-modal AAV targeting paradigms will benefit internal and external investigators
who strive for more refined targeting of cells and circuits relevant to substance use disorders.